Multilevel strategies to understand and modify the role of structural and environmental context on HIV inequities for sexual and gender minorities of color

PROJECT SUMMARY/ABSTRACT
Black, Latino/a/e/x, and Multiracial (BLM) sexual and gender minorities who have sex with men (SGMSM) in
the U.S. continue to experience a high and disproportionate burden of HIV, particularly younger BLM SGMSM
for whom HIV incidence continues to rise despite advances in HIV prevention. Evidence suggests that
differences in individual risk behaviors do not account for HIV inequities, and underscore the need to move
beyond models of individual-level risk factors to identify and intervene upon the socio-structural factors that
create and maintain inequitable risk environments. However, much of the research to date is limited in scope
and focuses individual-level risk or on cross-sectional HIV prevalence, which limits the ability to treat socio-
structural factors as dynamic or to investigate the environments within which risk behaviors occur. We are
submitting this application in response to RFA-AI-21-018 Limited Interaction Targeted Epidemiology to
Advance HIV Prevention (UG3/UH3). We propose to enroll a cohort of approximately 5,500 BLM SGMSM ages
16 and older in the U.S. and Puerto Rico who are at high risk for HIV infection. We will use a combined
approach to recruitment (sexual networking apps, social media, and other digital recruitment techniques) that is
adaptive to known shifts in digital technology. Participants will complete a survey and home-based sampling for
lab-based HIV testing at enrollment and annually thereafter for three years and an ecological momentary
assessment (EMA) for six weeks after enrollment. Concordant with study enrollment, we will develop novel
metrics to quantify socio-structural factors (state-level policy and social climate indicators) that create
intersectional oppression for BLM SGMSM, specifically structural racism, anti-LGBTQ stigma, and restrictive
HIV-related healthcare (Aim 1a). We will subsequently utilize the newly developed metrics from Aim 1a along
with local socio-structural factors (local-level HIV prevalence and socioeconomic indicators) and baseline and
EMA data to test the inequitable risk environments hypothesis to understand the role of state and local socio-
structural risk factors in HIV risk—this hypothesis will specifically test both the impact of socio-structural factors
on daily exposure to intersectional stigma and the interaction of socio-structural risk with individual behaviors
on undiagnosed HIV infection at baseline (Aim 2). These data will also be used to test a longitudinal model of
mechanisms through which state and local socio-structural factors directly and indirectly influence HIV
seroconversion and access to emerging HIV prevention technologies (e.g., emerging PrEP modalities) (Aim 3).
Study findings will be systematically reviewed and translated into guidelines for Ending the HIV Epidemic-
related public health policy and community-level interventions to reduce HIV inequities (Aim 1b). Developing
and testing a socio-structural model of HIV risk has strong potential to move the field beyond individually-
focused models of risk and improve the next generation of HIV prevention interventions aimed at reducing
disparities for this population.

Public health relevance
PROJECT NARRATIVE Black, Latino/a/e/x, and Multiracial (BLM) sexual and gender minorities who have sex with men (SGMSM) are at disproportionately high risk for HIV infection, yet little research has been powered to examine whether exposure to oppressive socio-structural factors vis-à-vis inequitable risk environments drives BLM SGMSM’s inequitable rates of HIV. In this study, we will establish a large nationwide cohort of BLM SGMSM and follow them longitudinally to examine socio-structural predictors (i.e., state- and local- level laws, policies, and social climate) of HIV seroconversion and access to emerging HIV prevention technologies (e.g., PrEP and ART). We will integrate Intersectionality and the Social Ecological Model to identify modifiable socio-structural targets for future public health policy and community-level intervention, with an emphasis on developing guidelines that can be integrated into the U.S. Ending the HIV Epidemic initiative to promote not only overall reductions in HIV but specifically target drivers of HIV inequities for BLM SGMSM.